WVDA AFRPS 2020

Project Summary
The West Virginia Department of Agriculture (WVDA), Regulatory and Environmental
Affairs Division (READ) functions as a consumer protection and consumer service
organization with the mission of enforcing laws, rules, and regulations to protect the public
food supply. Regulating the animal feed supply falls within the purview of WVDA READ.
By completing this project, WVDA READ plans to maintain and improve an effective and
consistent animal feed regulatory program.
The maintenance and improvement of the feed safety program will be achieved by
focusing on maintaining full implementation of the Animal Feed Regulatory Program
Standards (AFRPS). AFRPS implementation will be sustained by continuing program
audits and assessments as required in each standard, training staff, conducting
community outreach, maintaining an improvement plan, and making program changes
based on that plan. Other specific aims of this project include:
• Developing and sustaining innovative approaches to AFRPS implementation that
can be replicated by other regulatory agencies by using common software and
simple, streamlined standard operating procedures that can be easily shared;
• Supporting activities that promote the continuous improvement of AFRPS by
attending face-to-face meetings and contributing information to committees;
• Continuing to build relationships and communication with state and federal
regulatory agencies, such as the US Food and Drug Administration (FDA) by
maintaining a feed safety inspection contract, participating in meetings and audits,
and sharing information.
WVDA READ plans to enhance the feed inspection program during this project period.
An effective and consistent feed inspection program will assist in carrying out the mission
of the organization by ensuring the safety of the animal feed supply.

Public health relevance
Project Narrative The focus of this project is to improve the West Virginia Department of Agriculture (WVDA), Regulatory and Environmental Affairs Division (READ) feed regulatory program by maintaining implementation of the Animal Feed Regulatory Program Standards (AFRPS). AFRPS provides a framework for improving state animal feed regulatory programs and promotes a consistent methodology to animal feed regulation across jurisdictions. Continuing to implement AFRPS will enhance the protection of the animal feed supply, support principles of an integrated food safety system, and protect public health.